HEAD START CONNECTS: INDIVIDUALIZING AND CONNECTS FAMILIES TO FAMILY SUPPORT SERVICES

The primary goal of this project is to build knowledge about how Head Start programs across the country coordinate family well-being services for parents/guardians and tailor coordination processes to individual family needs. This aim will be accomplished through reviewing the literature, consulting with experts and stakeholders, conducting case studies of Head Start programs, as well as designing and potentially executing a large-scale descriptive study.